Optimizing Response to Chronic Pain Treatments in Veterans: Identifying Key Moderators

Abstract
Chronic pain is a prevalent, disabling problem affecting as many as 50% of men and 75% of women
Veterans. There is widespread recognition of the importance of developing effective complementary and
integrative health (CIH) treatments and the need to optimize their effectiveness. The CIH pain treatment
with the most empirical support is cognitive-behavioral therapy (CBT). However, not everyone benefits from
CBT. Prior research has shown that two CIH interventions, Mindfulness-Based Cognitive Therapy (MBCT)
and Hypnotic Cognitive Therapy (HYP-CT), are beneficial and offer alternatives to CBT and have similar
efficacy. However, as with CBT, individual response to these treatments also varies considerably. Our
preliminary data suggests the variability in treatment outcome may be due to important baseline patient
differences. This suggests the possibility that patients can be effectively “matched” to the treatments they
are most likely to benefit from, based on information that can be obtained before treatment starts. Research
is needed to develop patient-treatment matching algorithms that could match a given individual to the
evidence-based treatment most likely to be beneficial given their unique individual profile. The overall aim
of the proposed study is to address this need by identifying patient factors that determine who benefits
most from two CIH treatments and the current gold standard non-pharmacological treatment (CBT), relative
to usual care. This aim will be addressed using a clinical trial in which participants will be randomized to
one of the four treatment conditions. We will test hypotheses – developed from both theory and prior pilot
research – that pre-treatment brain activity patterns, hypnotizability, catastrophizing, and mindfulness
moderate pre- to post-treatment improvements in pain intensity associated with group-delivered CBT,
MBCT, and HYP-CT, relative to usual care, in Veterans with chronic pain. The findings will provide the
foundation for building an algorithm to support personalized care, whereby Veterans can be offered the
treatment that will be most beneficial for them. This study will also help develop knowledge about
potentially powerful alternatives to pharmacological/opioid analgesic approaches. Finally, the study findings
will be useful to health care providers and their patients to facilitate shared decision-making.

Public health relevance
Project Narrative While behavioral treatments for chronic pain are effective on average, some people benefit greatly from treatment while others benefit very little, and the same person may respond much more to one type of treatment than another. This project aims to better understand the patient factors that could be used to identify – before treatment –who will benefit the most from each of three different chronic pain treatments: cognitive behavioral therapy, Hypnotic Cognitive Therapy, and Mindfulness-Based Cognitive Therapy. The knowledge gained from this research will provide an essential platform for developing algorithms to effectively match patients with chronic pain to treatments that are most likely to be beneficial for them.